Immunogenomics Core

Abstract
The primary objective of the Immunogenomics Core is to perform comprehensive immunophenotyping,
functional analyses, and genetic and epigenetic monitoring in peripheral blood and the tumor microenvironment
and investigate tumor antigen-specific immune responses for the immunotherapeutic approaches being
developed and tested in Individual Research Projects 1-3 of the Roswell Park Ovarian Cancer SPORE. It will be
also responsible for immunologic and genomic assays for Career Enhancement Program (CEP) and
Developmental Research Program (DRP). In conjunction with the Biospecimen and Pathology Core, morphology
and localization of immune cells on pre- and post-immunotherapy tumor sections will be analyzed by highly
multiplexed Imaging Mass Cytometry (IMC). Additionally, in conjunction with the Biostatistics and Bioinformatics
Core, neoantigens, transcriptome analysis, epigenetic changes and TCR sequencing will be determined for
Individual Research Project 1 and 3. The Core will routinely provide SPORE investigators high quality, state-of-
the-art CyTOF, IMC, Seahorse assays, cell culture, cell isolation, flow cytometry, ELISPOT, ELISA, multiplex
cytokine bead array, RNA-seq, whole exome sequencing, TCR-seq, and Methyl-Seq.
The specific aims of the Immunogenomics Core are to:
1) Design and optimize immunologic and genomic assays for Individual Research Projects, CEP and DRP, and
provide state-of-the-art immunophenotyping, transcriptome analysis, TCR sequencing, epigenetic changes
and functional analyses of immune cells in peripheral blood and tumor microenvironment of patients who
receive advanced immunotherapies in the Ovarian Cancer SPORE.
2) Run whole exome sequencing for tumor and peripheral blood samples to identify mutations and HLA types
and confirm T-cell reactivity against the predicted neoantigens for DC-peptide vaccine in Individual Research
Project 3.
In addition to these established immunoassays, the Immunogenomics Core will be developing new
methodologies/markers and making them available to the SPORE investigators. It also has a significant
educational role, working with all SPORE investigators, including PIs, technicians and young investigators on
their assay development, proper use of instrumentation, and interpretation of their data.

Public health relevance
Narrative The Immunogenomics Core will be responsible for accurate and reproducible monitoring of immune and genomic changes in peripheral blood and tumor microenvironment in patients with ovarian cancer. The Immunogenomics Core will leverage the expertise of Center for Immunotherapy and Shared Resources at Roswell Park. Centralization and standardization of the performance of the immunologic and genomic assays will facilitate head-to-head comparisons of the immune/genomic signatures and changes being induced by cutting-edge immunotherapies in the Roswell Park Ovarian Cancer SPORE. The Immunogenomics Core personnel will work closely with Individual Research Project Leaders and Core Directors for accomplishing the projects and discovering novel findings through the immunologic and genomic data.